Multimodal study of cognitive impairment following radiation therapy for locally advanced head and neck cancer

PROJECT SUMMARY
Treatment of locally advanced head and neck cancer (LAHNC) commonly entails the use of radiation
therapy, which often exposes portions of the brain, particularly the cerebellum and inferior temporal lobes, to
moderately high doses of radiation. The negative effects of cranial radiation exposure on cognition are well
established in other types of malignancies, but remain unstudied in LAHNC patients. The underlying disease
process, chemotherapeutic agents, and radiation dose distribution in patients treated for LAHNC are
fundamentally different from the patient populations previously studied, suggesting that patterns of cognitive
impairment may also differ. This scientific proposal will elucidate the cognitive effects of radiation in LAHNC
patients through three specific aims. Scientific Aim 1 will characterize the cognitive profiles of LAHNC survivors
by administering a neuropsychological battery and patient questionnaires. Radiation dosimetry to individual
regions of the cerebellum and temporal lobes will be calculated from the original treatment plans. The effects of
patient and treatment characteristics (including chemotherapy exposure and radiation dosimetry) on post-
treatment cognition will be assessed. Scientific Aim 2 will determine the association between cognitive
impairment and germline variants. Germline single nucleotide polymorphisms will be determined using a
biologically-plausible, carefully curated candidate gene approach and assessed for association with the
neurocognitive battery results. Scientific Aim 3 will explore how modern radiation planning techniques can be
utilized to reduce brain radiation exposure for LAHNC treatment. Comparison radiation plans will be generated
using Multi-Criteria Optimized intensity modulation and proton therapy. This study will promote my long-term
career goal of improving quality of life for patients who received radiation therapy and will provide opportunities
for additional training and career development. The career development plan includes training in biostatistical
and research methodology, normal tissue complication probability modeling, and fundamentals of molecular
epidemiology and cognitive assessment. The scientific and training plans are supported by a team of
experienced mentors and advisors who are committed to the success of this project and my development as a
clinician scientist. The primary mentor is an expert in neurocognitive outcomes among cancer survivors, an
experienced mentor of young investigators, and the director of the UAB Institute for Cancer Outcomes and
Survivorship. The results of this proposal will be utilized to form the foundation of a future clinical trial designed
to reduce cognitive morbidity in LAHNC patients by identifying those patients at highest risk for cognitive
impairment, maximally reducing brain radiation exposure, and implementing a tailored cognitive remediation
intervention. This project will strengthen my skills as a clinical researcher, establish an independent research
platform, and make a true contribution towards improving clinical outcomes in cancer survivors.

Public health relevance
PROJECT NARRATIVE More than 80% of the 50,000 patients diagnosed with locally advanced head and neck cancer (LAHNC) each year will receive radiation therapy, which can expose portions of the brain to radiation. The overall prognosis for LAHNC continues to improve due to changing epidemiology and treatment advances, particularly for tumors of the oropharynx and nasopharynx, resulting in an ever increasing population of LAHNC survivors who are impacted by late morbidity from their treatment. This study aims to characterize the cognitive effects of radiation therapy for LAHNC, identify patient and treatment factors that are associated with worse post- treatment cognition, and explore how modern radiation treatment techniques can be refined to minimize brain exposure.